Impact of obesity and diabetes on coronary microvascular defects in HFpEF

Project Summary
Heart failure with preserved ejection fraction (HFpEF) is a complex and heterogeneous clinical syndrome
accounting for over 50% of patients with heart failure. Major HFpEF risk factors include age, hypertension,
diabetes, kidney disease and atherosclerosis. Prior studies have identified distinct phenogroups within the
overall HFpEF population which are defined based on different predisposing co-morbidities. However, the
links between these phenogroups and underlying pathophysiologic processes are poorly defined with
limited tissue-based evidence. Recognizing that obesity and type-2 diabetes are pro-inflammatory, and that
oxidative stress produces microvascular injury, I hypothesize that obesity and diabetes promote pathological
structural and functional microvasculature remodeling that contribute to the development of HFpEF. I will
test this hypothesis with a combination of observational and interventional studies using an animal model
of HFpEF that is well-matched to the task. The ZSF1-obese rat is a genetic model of HFpEF with two leptin
receptor mutations resulting in an obese, diabetic and hypertensive phenotype impacting multiple organ
systems. Control ZSF-1 lean rats have a single leptin receptor mutation and develop hypertension without
obesity or diabetes. I previously validated the accelerated development of HFpEF in ZSF1-obese vs. ZSF1-
lean rats. In Aim 1, I will compare the temporal progression of microvascular structural and molecular
changes in ZSF1-obese and lean rat myocardium using advanced morphological characterizations and
spatial transcriptomic and proteomic techniques that resolve to cell type-specific expression patterns. In
parallel, I will perform the same assays on banked myocardial specimens from a cohort of patients with
features of HFpEF and relevant controls. In Aim 2, I will connect these tissue-based findings from the obese
and lean rats with in vivo assessments of coronary microvascular function using micro single-photon
emission computed tomography (µSPCT). In Aim 3, I will employ treatment with a GLP-1 receptor to test
whether mitigation of obesity and diabetes can prevent and/or treat microvascular remodeling in the ZSF1-
obese rat. Beyond the scientific merits of the proposed research, conducting these studies will broaden my
understanding of cardiovascular pathophysiology and help develop my proficiency with several versatile
and powerful techniques. My primary mentor, Dr. Ken Margulies, is a senior physician-scientist with
expertise in myocardial pathophysiology and translational heart failure research using preclinical models
and human myocardium. I have an advisory committee with expertise in each new topic area or technique
(microvasculature, quantitative image analysis, spatial transcriptomics and proteomics, bioinformatics), and
they are committed to my training. I have the full support of my institution where the environment favors
dynamic and collaborative interactions among translational researchers and clinical experts. Together, the
research, training, mentors and institutional environment assures my successful transition to independence.

Public health relevance
Project Narrative Heart failure with preserved ejection fraction (HFpEF) affects over 50% of heart failure patients and its associated morbidity and mortality are increasing in the setting prevalent predisposing comorbidities: obesity, diabetes, and hypertension. This proposal seeks to understand how obesity and diabetes impact the progression of microvascular dysfunction in HFpEF over time and whether GLP-1 receptor agonists therapy can attenuate inflammation and progression of coronary microvascular dysfunction in experimental HFpEF. The data generated in this proposal will help define our understanding of how obesity and diabetes exacerbate the progression of HFpEF.